Center for Advancing Sociodemographic and Economic Study of Alzheimer’s Disease and Related Dementias (CeASES-ADRD)

See Overall – per RFA, DO NOT COMPLETE. This is being uploaded to remove the error under the eRA
System.

Public health relevance
See Overall – per RFA, DO NOT COMPLETE. This is being uploaded to remove the error under the eRA System.